Targeting Fibroblast Growth Factor Receptor-2b in prevention and treatment of cutaneous Squamous cell carcinoma.

Cutaneous squamous cell cancer (cSCC) is one of the most rapidly increasing cancers in the USA striking
200,000 Americans annually. Exposure to Solar UVB (ultraviolet B) radiation is the primary etiologic factor for
skin cancer. In organ transplant patients there is a 65–100 fold increased incidence of cSCC compared to the
general population. Targeted agents have been identified in other common skin cancers such as basal cell
carcinoma and melanoma but not for cSCC. Thus, novel mechanism-based targeted approaches are needed
for both prevention and treatment of aggressive cSCC. Further, excision of cSCC of the head & neck results in
significant facial disfigurement and thus chemoprevention for patients with condemned skin is critical. In our
preliminary studies, systemic administration and topical application of fibroblast growth factor receptor (FGFR)
inhibitor AZD4547 significantly decreased UVB-induced epidermal hyperplasia and hyper proliferation in SKH-
1 mice. Further, inhibition of FGFR was associated with downregulation of the mTOR and AKT signaling
pathway. AZD4547 also inhibited cSCC cell survival, migration and motility that translated into decrease tumor
growth in an in vivo xenograft model. Interestingly, deletion of FGFR receptor subtype; FGFR2 significantly
decreased mTOR and AKT signaling in cSCC cells suggesting an important role of FGFR2 in
AZD4547-mediated effects. Prior published studies demonsrtated a protective role of FGFR2b in the skin.
However, it is important to understand that the role of FGFR2b in the skin is highly context dependent
and critical experiments are needed to clearly identify its role in the pathogenesis of UVB-induced skin cancer.
Based on our preliminary data, our central hypothesis is targeting FGFR and selectively FGFR2 is
critical for prevention of cSCC. Accordingly, in Aim1, we will determine temporal effects of AZD4547 on
UVB-induced acute epidermal hyperplasia and hyper proliferation. In addition, we will also assess the effects
of AZD4547 on UVB-induced tumor promotion and progression. Aim2 will determine the time course for
UVB-induced FGFR activation and assess the effect of FGFR inhibition on downstream FGFR signaling.
Using K14.CreERT2 x FGFR2bflox/flox mice, the role of FGFR2b in modulating UVB-induced mTORC1 and
AKT activation will also be assessed. In addition, the source and type of FGFR2 ligands-induced by UVB in
the skin will also be studied. Aim3 will primarily focus on establishing the role of FGFR2 in UVB-induced
epidermal hyperplasia, apoptosis and skin carcinogenesis. Further, the role of FGFR2 in inhibiting the
progression of premalignant lesions to tumors will be studied. Finally, in Aim4, we will establish FGFR2,
pFGFR2 and pS6 as predictive markers for cSCC and tumor aggressiveness and as a potential target for
treatment of cSCC. We will also evaluate its efficacy in inhibiting growth of Patient-Derived Xenografts. The
ultimate goal is to provide an understanding for the role of FGFR and selectively FGFR2 in UVB-induced
skin cancer which will lead to development of targeted agents that could prevent and treat cSCC.

Public health relevance
Cutaneous squamous cell carcinoma (cSCC) is a keratinocyte-derived invasive and metastatic tumor of the skin and is the second-most commonly diagnosed form of skin cancer (16%) striking 200,000 Americans annually. Increased exposure to Ultraviolet-B (UVB) from solar radiation as a result of depletion of the ozone layer and popular use of tanning beds are the primary reasons for the increased incidence of cSCC. The growing organ transplant population are at a 100-fold increased risk for cSCC Thus, novel mechanism-based therapeutics are needed for prevention and treatment of cSCC. Studies proposed in this proposal will investigate the efficacy of pan FGFR inhibitor AZD4547 in skin carcinogenesis. Further, the role of FGFR2 receptor subtype in UVB-induced carcinogenesis will also be elucidated. Successfully completion of the proposed studies carries significant translational potential for FGFR inhibitors in organ transplant patients with aggressive cSCC and for prevention of UVB-induced skin carcinogenesis. .